Mechanisms of kinesin motor protein inhibition

MECHANISMS OF KINESIN MOTOR PROTEIN INHIBITION
SUMMARY
The spatiotemporal regulation of organelle positioning is critical for proper cellular function, especially as the
cell responds to a changing environment. The kinesin superfamily of motor proteins is responsible for various
cellular processes that range from long-range axonal transport to orchestrating the mitotic spindle during cell
division. The regulation of kinesin motor proteins occurs via inhibitory and activation-based mechanisms,
where kinesin motor proteins are subject to autoinhibition when not bound to a cargo. Recently, the discovery
of kinesin-binding protein (KIFBP) revealed a novel form of kinesin inhibition whereby KIFBP binds to kinesin
motor domains to block microtubule-binding. In this grant, we will determine the molecular basis for
KIFBP-mediated kinesin inhibition in trans and how kinesin light chains in cis-lead to kinesin inhibition. Based
on structural studies of KIFBP bound to two different kinesin motor domains, we developed a model of how
KIFBP remodels kinesin motors and how KIFBP selectively engages motors. We will introduce site-specific
mutagenesis based on crosslinking mass spectrometry and patient-derived mutants to dissect kinesin binding
and remodeling by KIFBP (Aim 1). In parallel, we will determine how light chains regulate full-length kinesin
motor proteins via autoinhibition. Despite decades of work into the regulation of full-length kinesin motor
proteins, there remain conflicting results regarding inhibition of kinesin motor domains. We are poised to
answer this question by exploiting a combination of crosslinking mass spectrometry, protein engineering, and
cryo-EM to determine how kinesin light chains stabilize a compact, inhibited kinesin motor (Aim 2). We will
study both kinesin-1 heterotetramers (KIF5B:KLC1) in addition to kinesin-2 heterotrimers (KIF3A:3B:KAP) to
compare and contrast how these different kinesin motor complexes are autoinhibited. Taken together, this work
will expand our understanding of kinesin regulation, establishing modes of inhibition to provide a complete view
of kinesin activity.

Public health relevance
NARRATIVE The kinesin superfamily of motor proteins orchestrates various cellular processes, necessitating careful control of kinesin activity. This project will determine the molecular details underlying kinesin inhibition via kinesin binding protein and kinesin light chain and provide a framework to understand how kinesin-driven cargo transport is regulated.